SUPPORT SERVICES FOR THE NATIONAL LIBRARY OF MEDICINE

The objective of this contract is to provide conference management and related technical and resource support services for the various programs of the National Library of Medicine.